Brief Interventions in the Emergency Department for Alcohol and HIV/Sexual Risk

DESCRIPTION (provided by applicant): Linkages between alcohol use and HIV/sexual risk behaviors have been observed in multiple groups and each behavior has been successfully treated individually. Indeed, some studies suggest these behaviors can be successfully treated together. The Emergency Department (ED) provides a venue through which many patients with multiple risks are treated. Yet, to date no study has addressed these behaviors together in an ED, where admission may represent an opportunistic moment when patients are particularly willing to discuss these risky behaviors. Motivational Interviewing (MI) has demonstrated promise with alcohol risk in the ED in several of our previous studies, and has shown promise with sexual risk populations as well. Accordingly, this study (N=302) will address whether a two session multiple risk MI can more effectively decrease and maintain reduction in alcohol use, alcohol related problems, and sexual risk taking following discharge from the ED than Brief Advice (BA). Baseline, MI Session 1 and BA will be administered in the ED. MI Session 2 will occur 7- 10 days following MI Session 1. Follow-ups will be conducted at 3, 6 and 12 months. This proposal will allow us to address the next phase of our program of research that has been designed to develop easily disseminable treatments for high-risk populations in medical settings. This study will also address potential mediators (motivation to change risk taking, self-efficacy) of MI effects. We will also examine whether reductions in sexual risk associated with MI compared to BA are accounted for by reduced drinking. A tertiary aim will examine the moderating effect of co-occurring substance use on outcomes. The cost-effectiveness of the interventions will also be addressed. Thus, this study will address two significant Public Health problems and provide significant information about MI mechanisms that may be relevant to the treatment community.

Public health relevance
PUBLIC HEALTH RELEVANCE: This brief alcohol and sexual risk taking intervention has the potential to influence the public health by reducing alcohol use and sexual risk taking behavior in individuals who are seeking treatment in an Emergency Department. Project Narrative This brief alcohol and sexual risk taking intervention has the potential to influence the public health by reducing alcohol use and sexual risk taking behavior in individuals who are seeking treatment in an Emergency Department. __SpecificAimsTextDelimiter__ A. Specific Aims Brief Interventions addressing alcohol risk and HIV/sex-risk behaviors have been successfully tested, but there are very few developed interventions for alcohol and sex risk in combination, and none that have been conducted in the ED. Given the co-occurrence of alcohol and sexual risk, the feasibility (Mehta et al., 2007) and acceptability (Merchant et al., 2007) of ED-based sexual risk screening, and the success of prior brief interventions in the ED for alcohol (Havard et al., 2008), an important next step is to assess the efficacy of an intervention that addresses both behaviors. The proposed project is designed to build on our success implementing and testing Motivational Interviewing (MI) in the ED setting (e.g., Colby, et al., 1998; Monti, et al., 1999; Monti, et al., 2007; Monti, 2009; Spirito, et al., 2004), and to continue our systematic progression of testing MI against control group variants. Given the dearth of literature on a combined intervention, the primary goal of this study is to examine whether a Motivational Interview addressing both behaviors can more effectively decrease and maintain reductions in alcohol use and related problems and in sex risk behaviors than Brief Advice (BA) for reducing these risks. Using a 2-group randomized controlled design we will determine the differential efficacy of MI vs. BA; findings will add to the existing literature on the use of MI in medical settings, provide the notable addition of including sex risk as a frequently co-occurring behavior, provide information on putative mediators, and evaluate cost-effectiveness. The specific aims of the study are as follows: Primary Aims: The primary aims address the differential effectiveness of the two conditions, MI and BA. 1. We will investigate the effects of MI on alcohol use and alcohol-related problems at 3, 6 and 12 months follow-up when compared to BA. MI is hypothesized to have a larger effect than BA only. 2. We will test the hypothesis that MI will have a greater effect on sex-risk behaviors at 3, 6 and 12 months follow-up than effects on these behaviors in the BA condition. Secondary Aims: Secondary aims will explore potential processes by which these interventions may influence alcohol use and/or sex risk and their cost effectiveness. 1. We will test the hypothesis that increases in readiness to change and self-efficacy will mediate the effect of MI on alcohol use outcomes when compared to BA. 2. We will test the hypothesis that increases in readiness to change and self-efficacy will mediate the effects of MI on sex-risk outcomes when compared to BA. 3. We will test the hypothesis that reductions in alcohol use will mediate sex-risk reductions. 4. We will compare the cost effectiveness of MI compared to BA for alcohol and sex-risk outcomes. Tertiary Aims: 1. We will test the hypothesis that MI will have a greater effect on the likelihood of completing HIV/STI testing than BA. 2. We will examine whether the co-occurring use of substances other than alcohol moderates the efficacy of MI compared to BA. In addition, we will test the exploratory hypothesis that MI will result in greater reductions in substance use at 3, 6, and 12 months follow up than BA.